Identifying the burden of hospitalization due to Rhinovirus (RV) in children and mechanisms of pathogenesis using airway molecular profiling

PROJECT SUMMARY/ABSTRACT
Rhinoviruses (RVs), underestimated in the past as simply the cause of the common cold, are increasingly
appreciated as a major cause of severe, acute respiratory illnesses involving the lower respiratory tract (LRT)
across all age groups. As the most frequent cause of the common cold for both children and adults, RVs set the
stage for secondary bacterial infections (acute otitis media and sinusitis) responsible for serious medical, social
and economic consequences. RVs are 2nd to respiratory syncytial virus (RSV) as a cause of bronchiolitis in
infants and toddlers resulting in numerous Emergency Department visits and hospitalizations. They are also
recognized as the most important triggers for asthma exacerbations in children and adults, as well as chronic
obstructive lung disease in adults, leading to substantial morbidity and rare mortality. RVs have long been
appreciated as a cause of LRT infection in immunocompromised children and adults. However, the role of RVs
as an important cause of community acquired pneumonia (CAP) in either children or adults is still a matter of
debate. This is in large part because of the high frequency of subclinical RV infections which complicate the
interpretation when RVs are identified in persons with serious respiratory disease.
The goal of this study is to determine the burden of RVs as a cause of acute, severe, respiratory illnesses leading
to hospitalization. We will create a cohort of children in Madison, Wisconsin. They will be enrolled in the 2nd year
of life and followed longitudinally (when well and sick) for 36 months to identify the circulating RVs and provide
samples to confirm/establish a host nasal transcriptome differentiating clinical RV infections from subclinical RV
infections and clinical infections caused by other respiratory viruses. Simultaneously, we will evaluate all
episodes of severe, acute respiratory infection, including CAP, admitted to the American Family Children’s
Hospital to determine etiology in general and the role of RVs in particular. We will be able to determine the
precise proportion of cases of lower respiratory tract illness, including CAP, that are actually caused by RV, a
current gap in our clinical knowledge. We hypothesize that the nasal transcriptome will provide a signature for
RV in subjects with severe, acute LRT infection that will distinguish it from asymptomatic infection and that study
of host transcriptomics in severe cases of RV infection will identify immune/inflammatory defects and other
targets for management. This will have vitally important implications for antibiotic stewardship and development
of management strategies including vaccines and other therapeutics. Given the commanding role of RV in
respiratory infections (especially as a reduction of RSV is on the clinical horizon), there must be increased efforts
at both prevention of and intervention for RV infections.

Public health relevance
PROJECT NARRATIVE This study will establish the burden of rhinoviruses (RVs) as a cause of acute, severe, respiratory illnesses leading to hospitalization in children. Using nasal transcriptomics, we will establish the host signature which distinguishes clinical from subclinical RV infections and thereby enable determination of the precise proportion of lower respiratory tract infections actually attributable to RV. Meticulous longitudinal study of the host transcriptome in severe RV infections will identify immune/inflammatory defects as targets for intervention to limit or prevent RV disease, enhance antimicrobial stewardship, and improve the public health.